Data Management Core

The Data Management Core serves as the central location for quantitative and qualitative data management, data analysis, and data sharing for the proposed Learning Disabilities Research Center (LDRC), Learning Disabilities Translational Science Collective: Building on the Florida LDRC. To support the center, the Data Management Core has three specific aims. Aim 1: To provide leadership, services, and flexible systems for data collection and management for all projects. Aim 2 is to provide guidance on research design and statistical analysis to each of the core projects. Aim 3 to provide expertise and assistance to share data resulting from the projects. In addition, in Aim 4, we will support the center as well as the broader research community by developing products and trainings to provide career enhancement efforts for all early career scholars, including opportunities for the broader, external research community beyond the LDRC.